Novel Hydrogel Film to Reduce Pain Experienced during Sexual Intercourse for Women with Vulvodynia

The goal of this project is to develop a non-pharmaceutical hydrogel film and corresponding applicator delivery
system that helps mitigate pain receptor activity during sexual intercourse for women with gynecologic pain
conditions, specifically vulvodynia and vestibulodynia. Several solutions exist that attempt to eliminate vulvar
pain, but their designs fall short. Pharmaceuticals such as opiates, anesthetics, anticonvulsants, estradiol, and
antidepressants are commonly prescribed to patients diagnosed with vulvodynia and vestibulodynia; however,
none of these have been indicated for vulvodynia by the FDA and have an overall lack of validation.
Additionally, these pharmaceutical options often have negative consequences on patients and do not
guarantee immediate and safe pain-relief during sexual intercourse, especially with continual use. Although
etiology of vulvodynia is still unknown, we do know that vulvodynia is triggered by pressure on sensitive
nociceptors, especially located in the vaginal vestibule. Reducing pressures on sensitive tissue has been
shown to eliminate the sensation of pain, but there are currently no solutions that reduce the forces on vulvar
tissue during sexual intercourse. Pelva Health proposes the development of a force dissipating hydrogel film
that reduces pressure on the vulva, vestibule, and vagina will allow for immediate pain-free sexual intercourse.
Once developed, our hydrogel film and corresponding applicator will be studied clinically for effectiveness in
mitigating pain experienced during sexual intercourse by women with vulvodynia and vestibulodynia in a Phase
II clinical study. With no technology currently indicated for vulvodynia and vestibulodynia with the Food and
Drug Administration, Pelva Health has potential to undergo breakthrough designation for the first ever device
indicated for vulvodynia and vestibulodynia.

Public health relevance
The goal of this project is to develop a hydrogel film that provides pain relief during sexual intercourse for women with vulvodynia and vestibulodynia.There are currently no technologies indicated for vulvodynia or vestibulodynia with the FDA. However, despite minimal advances in vulvodynia pain management, Pelva Health has identified a novel way to mitigate pain receptor response during sexual intercourse by focusing on pressure thresholds that cause nociceptor activation in the vulva, vaginal vestibule, and vagina.